Hematology Clinical Research Training Program

Hematology Research Training Program (T32 HL-07439) PI/PD: Brass, Lawrence F.
Abstract
The Hematology Research Training Program (HRTP) at the University of Pennsylvania was established in the
mid-1970’s. It has received NHLBI T32 funding since 1978 and to date it has provided support for 179 predoctoral
and postdoctoral trainees. The program’s mission is to sustain the hematology workforce by providing basic and
translational research experiences, training, career advising and mentorship to a diverse group of physician-
scientists and scientists. Our goals for the next 5 years include 1) providing the training and mentorship that will
allow our graduates to become successful investigators in settings that include academia, industry, federal
agencies, and the NIH and other research institutes, 2) helping to grow the research workforce in areas related
to hematology, blood cells and blood disorders, and 3) working with other T32-funded hematology research
training programs to exchange best practices and allow individual trainees to benefit from a wider network. The
current program directors are Lawrence Brass, MD PhD and Ivan Maillard, MD PhD, both of whom are members
of Penn’s Hematology-Oncology Division, where Dr. Maillard is the Vice Chief for Research and Dr. Brass directs
the MD/PhD program. The diverse participating faculty includes 47 trainers of all academic ranks. Policies are
in place for adding or removing trainers from the roster. Participation in mentorship training is expected by all.
NHLBI T32 support for the HRTP currently includes 8 clinical fellows and postdocs plus 4 MD/PhD and PhD
predocs. Renewed funding is requested at the same level. Participating graduate programs are primarily those
within the Biomedical Graduate Studies (BGS) umbrella program, but some trainees will be in the Chemical &
Biomolecular Engineering (CBE) program. Key features of the HRTP include formal and informal advising,
workshops, attendance at national conferences, and training in the responsible conduct of research and methods
to enhance reproducibility. There is a well-received annual presentation and feedback session attended by our
Internal and External Advisory Boards, whose membership includes the directors of 5 other T32-funded research
training programs. Program outcomes. 143 postdocs (31 MD/PhD, 65 MD and 47 PhD) and 36 predocs (23
MD/PhD and 13 PhD) have been supported to date. Of the 153 who have completed all subsequent stages of
training, 76% have positions that we consider appropriate outcomes for alumni of this training program, including
71 (46%) who have full-time appointments at academic institutions or the NIH, and 31 (20%) who are employed
in the biotech and pharmaceutical industries. In this proposal we present a plan for attracting, training and
mentoring a diverse group of individuals, monitoring their progress during training, and tracking their journeys
afterwards. A logic model and rubric have been developed to allow us to combine outcomes data with trainee
feedback and alumni suggestions to improve the program.

Public health relevance
Hematology Research Training Program (T32 HL-07439) PI/PD: Brass, Lawrence F. Narrative As the pace at which biomedical research advances increases, there is a greater need than ever for physician- scientists and scientists who are trained to work at the intersection between medicine and science. The goal of the Hematology Research Training Program is to identify, train and mentor a diverse group of outstanding men and women and to help them become teachers, scholars, and leaders of biomedical research in academia, industry with an emphasis on fields of endeavor that are applicable to the broad range of hematology.